Evaluating a mobile application to reduce distress in breast cancer survivors using an adaptive design

Project Summary/Abstract
Psychological distress in breast cancer survivors is highly prevalent, significant, and costly. Studies show that
nearly half of all breast cancer survivors will experience clinically significant symptoms of depression and/or
anxiety in the first five years after their cancer diagnosis. There is robust evidence that cognitive behavioral
therapy (CBT) is an efficacious intervention for distress in cancer survivors. Unfortunately, access is
significantly limited by a lack of trained clinicians and expense. To overcome these barriers, smartphone
applications (`apps') have emerged as a feasible and effective method to provide low-cost delivery of health
information and treatment. To our knowledge, there are no publicly available mental health apps that have
been rigorously tested with cancer survivors. Members of our research team previously developed and
validated a publicly available, fully automated app-delivered mental health intervention, IntelliCare, which is
based on tenants of CBT. We recently conducted a pilot of the IntelliCare app suite in breast cancer survivors
and found that its use led to a significant reduction in symptoms of depression and anxiety, with particularly
robust effects among those with a moderate level of distress or greater upon study enrollment. The positive
result from our single-arm pilot leads us to the next logical step of testing the efficacy of the IntelliCare apps
against a robust control in a randomized study with long-term follow-up. The goals of this project are: (1) to
evaluate the efficacy of the IntelliCare apps in reducing symptoms of depression and anxiety in breast cancer
survivors, and (2) to test the impact of human coaching as a way to increase engagement with the intervention.
Using an innovative experimental design, called the Sequential, Multiple Assignment, Randomized Trial
(SMART), 313 breast cancer survivors with elevated symptoms of depression and anxiety will be randomized
to initially receive the IntelliCare apps or app-delivered Patient Education. We will test the effects of the
IntelliCare apps on symptoms of depression and anxiety at post intervention, 6 and 12 month follow-up (Aim
1). During the first week of app use, we will identify participants that are low-engagers of the IntelliCare apps.
These low-engagers will be re-randomized to receive coaching in addition to the apps vs. no change (i.e.,
continue using the apps naturally), to test the added value of coaching on engagement (Aim 2). Finally, we will
conduct semi-structured exit interviews with participants who receive the IntelliCare apps. Interviews will
capture survivors' perceptions about the extent to which, and how, tailoring the apps and coaching specifically
for breast cancer survivors may improve intervention outcomes and engagement. (Aim 3). Adaptive
approaches to promoting engagement, such as added coaching for those who struggle to engage, will balance
the competing needs for scalability and individualized attention to address rapidly expanding survivorship care
needs.

Public health relevance
Project Narrative Psychological distress, presented through symptoms of depression and anxiety, is very common among breast cancer survivors, and it is critical that easily accessible, helpful, and engaging interventions are made available. IntelliCare, an app-delivered intervention, has been shown to be highly effective in reducing symptoms of depression and anxiety in the general population, suggesting strong potential for public impact among breast cancer survivors. This proposal will evaluate the efficacy of IntelliCare to reduce symptoms of depression and anxiety for breast cancer survivors, as well as the added value of human coaching to increase engagement, resulting in an adaptive intervention design for breast cancer survivors that is low cost, easily accessible, and highly efficient.